Development of a versatile paired prime editing toolkit for CFTR gene correction

PROJECT SUMMARY
Mutations in the Cystic Fibrosis Transmembrane Conductance Regulator (CFTR) gene are the primary cause of
cystic fibrosis (CF) and are associated with many other genetic diseases. Thus, CFTR is a compelling therapeutic
target for treating various CFTR-related disorders. Genome editing techniques can correct the defective genes
at their native locus and permanently restore the gene function, potentially offering a one-time curative treatment
for CF. However, given that over 1,700 CF-causing mutations have been identified in the CFTR gene, mutation-
specific genome editing methods, such as base editing, may not be suitable for correcting the wide range of
CFTR mutations. To address these limitations, we propose to develop a more generalizable genome editing
strategy for CFTR correction. Because most CFTR mutations occur within the exons or at the exon-intron
boundary, we propose to replace the frequently mutated exons with their wild-type counterpart. Therefore, a
single set of gene editing agents can correct all the mutations within the same exon. Prime editing (PE) employs
an extended guide RNA (pegRNA) as a template for a conjugated reverse transcriptase to incorporate desired
edits into the targeted genomic site. Recently, we devised a paired prime editing strategy to program the
replacement of target genomic sequences without requiring a DNA donor in vitro and in vivo. Building upon this
work, the goal of this proposal is to develop paired prime editing-based sequence replacement strategies to
correct a broad spectrum of CFTR mutations, regardless of the mutation types or locations. We hypothesize that
replacing the defective CFTR exons with corrected ones will effectively restore CFTR protein expression and
function in vitro and in vivo. In the proposed research, we will utilize a donor-free sequence replacement strategy
to replace individual CFTR exons without creating double-stranded DNA breaks or requiring a DNA donor (Aim
1). To further expand the editing scope and efficiency of the paired prime editing approaches in inserting or
replacing large DNA sequences, we will develop a paired PE-based homology-independent insertion strategy
and apply it to correct CFTR mutations caused by large deletions or occurred in the large exons (Aim 2). Finally,
we will explore the therapeutic applications of the newly-established paired prime editing-mediated gene
correction strategy by delivering the genome editing agents to the lungs of a CF mouse model (Aim 3).
Successful completion of this project will result in a gene therapy strategy tailored for CF and provide a universal
gene correction framework for treating genetic diseases of high allelic heterogeneity.

Public health relevance
PROJECT NARRATIVE Genome editing techniques can correct the defective genes at their native locus and permanently restore the gene function, potentially providing a one-time curative treatment for genetic diseases. This study aims to engineer a generalized gene correction toolkit to address the broad spectrum of disease-causing CFTR mutations and explore its therapeutic applications in vivo. Findings from this work will pave the way for a gene therapy strategy for cystic fibrosis as well as various genetic diseases with high allelic heterogeneity.